Development of Degradable Fibers with Hemostatic Properties

PROJECT SUMMARY
Recent evolutions in the field of hemostatic materials have focused on developing products with high hemostatic
efficiency. An ideal hemostatic material should quickly control hemorrhaging, exhibit biocompatibility and
degradability, promote wound healing and be lightweight and inexpensive. Electrospinning degradable
macromolecules like collagen, chitosan, polycaprolactone yields nanofiber which have shown promise in wound
healing and bleeding cessation applications. Modern bleeding cessation treatments should have degradable and
regenerative capabilities but little research has been published on the utilization of synthetic analogs to costly
biomolecules. The long-term goal of this project is to generate a better understanding of polymer-based
hemostatic wound healing materials and cellular responses towards these materials for implementation in
regenerative treatments.
As a step towards this goal, a degradable collagen strand analog must be synthesized, electrospun, and
compared to other scaffolds for in vitro and in vivo evaluation. It is hypothesized that a biomimetic synthetic
polymer can be electrospun into an affordable, biocompatible, degradable, hemostatic wound dressing material
that will not only catalyze coagulation but also will not require surgical removal.
This proposal is significant because it represents the first attempt to incorporate a polyester-based
collagen mimic into electrospun scaffolds with the ability to control scaffold composition to combine desired
properties and functionalities in an ideal material for wound healing and hemostatic applications. This approach
is innovative because it will determine the feasibility of utilizing a synthetic collagen mimic in applications such
as electrospun wound healing and bleeding cessation materials. It is anticipated that the collagen-like
functional groups on the novel polyester coupled with the presence of chitosan in the fibers will lead to
bleeding cessation in wound models with suitable degradation rates. Furthermore, undergraduate students will
conduct the majority of the research in this proposal. This will be a significant research experience for these
students and will provide them with valuable laboratory and research skills that will be essential in their
careers.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to develop degradable, biomimetic fiber mats that help stop bleeding. Successful completion of this project may provide new affordable and effective material to be used in emergency settings.